Development of a novel checkpoint inhibitor-TGF beta combination therapy to reverse immune suppression and increase survival rates in advanced colorectal cancer patients

SYNTHIS SBIR Ph I PROJECT SUMMARY/ABSTRACT Colorectal cancer (CRC) is the 3rd most common cancer and the 2nd leading cause of cancer deaths in the US. Approximately 15-20% of CRC patients have high microsatellite instability (MSI-H). Although the FDA- approved immune checkpoint, anti-PD1 antibodies, nivolumab and pembrolizumab are effective in MSI-H CRCs, patient response rates are a modest 28-35%. The remaining 80% of CRC patients that are microsatellite stable (MSS) do not respond to anti-PD1/PDL1. With considerable room to improve in both populations, new combination IO treatments should 1) boost responses in MSI-H patients, and/or 2) offer new treatment options for the majority of checkpoint-resistant CRC patients with immunosuppressed “cold” tumors. TGF?β is an immuno-suppressive cytokine, with elevated levels in late stage CRC patients that cripple the adaptive immune system and decrease survival rates. In murine colon cancer models, blockade of the PD1 pathway led to a compensatory increase in TGF?β signaling, while blockade of both pathways led to tumor regression. Because historically systemic TGF?β blockade cause an array of significant issues, including host toxicity, novel TGF?β therapies are required to convert IO therapy-resistant “cold” CRCs into immunogenic “hot” tumors to drive tumor clearance. At Synthis, we are developing a novel, more aggressive checkpoint therapy combined with TGF-β inhibition (named: PTA) to eradicate CRC. In Aim 1, we will demonstrate that PTA reverses immune-suppression in vitro, and restores pathways critical for tumor clearance, such as IFN?γ expression and cytotoxic T cell mediated tumor killing. In Aim 2, we will test PTA in colon cancer models in vivo, using the humanized HuGEMM PD1 mouse model, which expresses human PD1 on T cells. PTA will be tested in an in vivo PD assay to establish the appropriate dose range to use in efficacy studies. We will then test PTA for efficacy in the MC38 colon cancer model in vivo, as well as harvest tumor infiltrating lymphocytes (TILs) to investigate the effect of PTA on immune cell infiltration and/or activation. The ultimate goal of PTA is to convert “cold” CRC tumors into immune infiltrated “hot” tumors and increase patient survival rates. New combination studies with anti-PD1 plus IO therapies are in high demand. Because CRC patients are resistant to single anti-PD1 therapies, a novel, more aggressive IO approach is required. With a predicted CRC global market size of $11B in 2022, PTA will be positioned as a single IO therapy that will eliminate two validated immuno-suppressive pathways to treat CRC patients and increase patient survival.

Public health relevance
SBIR PHASE I PROJECT NARRATIVE The majority of advanced colorectal cancer (CRC) patients do not respond to immune checkpoint blockade. Therefore, novel and more aggressive immunotherapies are in high demand. At Synthis, we are developing a differentiated therapy that blocks multiple immunosuppressive pathways simultaneously to treat CRC patients.